Synaptic activity-driven Abeta generation and aggregation

PROJECT SUMMARY/ABSTRACT:
Numerous biochemical and biophysical studies have demonstrated that amyloid-β (Aβ) aggregates into
toxic oligomers and fibrils when the concentration of the peptide is elevated and the pH is low (Paredes-Rosan
et al. 2019; Zhao et al. 2018). Aβ aggregates can be detected neuron throughout the endo-lysosomal pathway
(Brewer et al. 2020) where pH ranges from 4.5-6.5 which are prime conditions for Aβ to aggregate. However,
what physiological processes influence Aβ aggregation in vivo within this compartment remain unknown.
Elevated synaptic activity increases the formation of Aβ within endosomes before it is secreted into the brain
interstitial fluid (ISF) (Cirrito et al. 2005, 2008). We hypothesize that elevated synaptic activity not only
causes formation of Aβ, but also directly drives formation and release of Aβ aggregates. We propose
that low, physiological synaptic activity causes release of Aβ monomer, whereas high bursts of aberrant
activity reach a threshold when the combination of low pH endosomes with sufficiently high Aβ levels induces
aggregation. We have developed a novel electrochemical micro-immunoelectrode (MIE) technology to
measure Aβ40, Aβ42, or Aβ oligomer levels every 60 seconds in an awake, moving mouse for up to 6 hours in
order to tightly link the amount of synaptic activity with the level and conformation of Aβ. Furthermore, we will
determine if glutamatergic or GABAergic neurons are primarily responsible for producing Aβ and if one type of
neuron is more prone to generate aggregates. All studies will use the APPNLF/NLF knock-in mouse model of
amyloidosis in order to preserve normal expression patterns of APP which is critical for these types of studies.
Our preliminary data demonstrates the tight link between synaptic activity and Aβ generation, as well as the
characterization and specificity of the MIE technology for real-time detection of Aβ levels and aggregates.
Using the MIE, preliminary data suggest that only a slight increase in neuronal activity produces Aβ monomer
but that higher levels of activity induce secretion of Aβ aggregates. Also, our data suggests that excitatory
neurons produce more Aβ than inhibitory neurons. While we propose that synaptic activity is a potent regulator
of Aβ oligomer and fibril formation, we acknowledge that there are several means that will induce and influence
aggregation, such as chaperones like apoE, and that synaptic activity is just mechanism that can generate
these toxic species.
Aim 1 will determine the threshold of synaptic activity that causes Aβ to aggregate into soluble oligomers
then get released into the brain ISF. Aim 2 will determine whether excitatory or inhibitory neurons release Aβ
monomer or Aβ aggregates, and if that differs between wake and sleep states, since inhibitory tone is much
greater during sleep. Aim 3 will determine if chronically modulating activity of excitatory or inhibitory neurons
within the hippocampus alters development of Aβ plaques.
How synaptic activity impacts Aβ species and aggregation state is unclear. The scientific premise of this
proposal is to understand the mechanisms that contribute to Aβ generation and aggregation in vivo. The FDA
recently approved a monoclonal antibody, Lecanemab, that targets Aβ oligomers and finally has clinical
benefits to patients. Understanding the source of oligomers could inform on risk factors that influence
aggregation and lead to new therapies targeting oligomers in the future or identifying novel biomarkers for
disease development.

Public health relevance
PROJECT NARRATIVE: Amyloid-β (Aβ) accumulation as toxic oligomers and plaques are hallmark pathological changes that occur early in an Alzheimer’s disease brain and progress throughout the course of disease. This proposal will determine if elevated synaptic activity, a basic function of the brain in action, not only causes formation of Aβ but also induces it to aggregate into toxic species. Furthermore, we will determine which neuronal type produces these aggregates and if chronic modulation of specific neurons has a long-term impact on Aβ plaques.